Advanced Heart Failure: Epidemiology and Outcomes

PROJECT SUMMARY/ABSTRACT
Advanced heart failure is characterized by progressive debilitating symptoms and repeated hospitalizations
that degrade quality of life. There is no one criterion to diagnose advanced heart failure; the definition is
complex and challenging to apply broadly to populations. As such, our knowledge of advanced heart failure is
truncated and skewed as it is based on information from referral populations and convenience samples.
Enhancing our understanding of the epidemiology, experiences, and outcomes of patients with advanced heart
failure is critical to developing interventions to improve care and quality of life. To address these gaps in
knowledge, this proposal leverages diverse data sources and novel applications of quantitative and qualitative
methods to assess the epidemiology and outcomes of individuals with advanced heart failure.
In Aim 1, we will apply an advanced heart failure definition to a geographically-defined population of individuals
with heart failure under the auspices of the Rochester Epidemiology Project. We will determine the prevalence
of advanced heart failure, examine the demographic and clinical features of the population, and evaluate the
timing of its development and association with risk of outcomes. In Aim 2, we will use machine learning
techniques to develop computer algorithms (computable phenotypes) to identify patients with advanced heart
failure using electronic health record data. We will then leverage the infrastructure of the National Patient-
Centered Clinical Research Network (PCORnet) to validate the performance of the computable phenotypes
across diverse patient populations. This will enable the accurate and efficient identification of advanced HF for
future applications. In Aim 3, we will use the computable phenotype developed in Aim 2 to prospectively
identify individuals living with advanced HF. We will then assess their treatment and illness burdens using a
combination of surveys and semi-structured qualitative interviews. This information will be used to inform the
development of a palliative care intervention that is tailored to the needs of patients with advanced HF. We will
assess the acceptability of the tailored palliative care intervention to stakeholders (patients, caregivers,
clinicians).
The results of these analyses will provide synergistic information to clarify the epidemiology, case mix,
burdens, and outcomes of individuals with advanced heart failure. They will provide a prototype palliative care
intervention tailored to decrease burden and improve quality of life in advanced heart failure. Finally, the
computable phenotype developed can be used to identify patients with advanced HF for future quality
improvement programs, observational studies, and interventional research.

Public health relevance
PROJECT NARRATIVE Some patients with heart failure (HF) develop end-stage, refractory disease (advanced HF), characterized by progressive debilitating HF symptoms that interfere with daily life. However, our knowledge of the epidemiology and impact of advanced HF is severely limited because the definition is complex and challenging to apply broadly to diverse populations. In this study, we will evaluate the epidemiology and outcomes of advanced HF in a geographically-defined population, develop computer algorithms that can accurately and efficiently identify advanced HF, and assess the burdens and experiences of patients living with advanced HF to enable the design of new interventions to improve care and quality of life.